1/2-Bangladesh Center for Global Environmental and Occupational Health- Bangladesh

PROJECT SUMMARY
Almost 3 billion people worldwide, including 89% people in Bangladesh, are exposed to harmful
household air pollutants (HAP) emitted from combustion of biomass (wood, agricultural residue, cow dung,
etc.) fuel use for cooking. While health risks associated with air-pollution have been reasonably well-studied in
developed countries, there is little evidence on health benefits achievable by HAP reduction through clean fuel
use, especially in low- and middle-income countries (LMICs). Bangladesh GEOHealth hub has established a
cohort of biomass fuel users (n=660). We observed that an increased HAP exposure was associated with lung
function decline, increased blood pressure and disruption of innate and adaptive immune function. We
observed a drastic reduction in HAP exposure by exclusive liquified petroleum gas (LPG) stove use for 24
months, resulting changes in immune and inflammatory responses in women and in children. However,
changes in chronic cardio-pulmonary markers were challenging mostly due to short duration of follow up. In
quest for an innovative cost effective, adaptable, and scalable intervention as the possible next step, we
planned to conduct a large household level randomized controlled trial by educational intervention using mobile
phone (mHealth) based technology. In addition, we will continue following the cohort and will conduct rigorous
and repeated personalized (24-48 hours) and area (over 5 days) assessments of PM2.5 and black carbon (BC)
exposure to examine the long-term effects of HAP reduction on subclinical measures of cardio-pulmonary and
immune dysfunction including effect of HAP exposure on antibody response to vaccine. We will also use deep
learning methods to identify lung pathology in relation to HAP. Finally, we propose two exploratory studies on
health effects of industrial waste and garment industry work. The aims of this study are scientifically important
and directly policy-relevant and consistent with the GEOHealth program agenda.
1

Public health relevance
PROJECT NARRATIVE The majority of the low- and middle-income countries (LMICs) including Bangladesh are confronted by severe environmental and occupational health related challenges because of rapid urbanization, unplanned industrialization and sub-optimal regulation, control, and remediation. The main research focus of this U01 proposal is to evaluate the changes in preclinical markers of cardio-respiratory and immune dysfunction in relation to reduction of household air pollution achieved through exclusive clean fuel use for cooking. We also plan to conduct pilot studies exploring health effects of industrial waste and garment industry work – two other emerging GEOHealth topics relevant for Bangladesh and many other LMICs. 1